Family Stress, Coparenting, and Infant Development among Immigrant Arab-American Families

PROJECT SUMMARY/ABSTRACT
Approximately 3.7 million Arabs live in the United States; however, they are largely absent from
research on child health and development. Family stress due to immigration may be associated with negative
infant outcomes and poorer development. In contrast, family resources may relate to better infant outcomes.
Coparenting, defined as the way that parents coordinate and support each other in their parental roles, also
associated with infant outcomes. However, no published research has investigated the associations of
migration-related family stress, family resources, and coparenting with infant outcomes among immigrant
families. The purpose of this study is to examine the associations among family stress, family resources,
coparenting and infant outcomes among immigrant Arab American families. We aim to: 1) Examine the
associations of family stress, family resources, and coparenting with infant stress (hair cortisol, salivary
telomere length); and 2) Examine the associations of family stress, family resources, and coparenting with
infant development.
Using a cross-sectional design, 120 immigrant Arab American families of infants ages 9-12 months will
be recruited from the Women, Infants and Children (WIC) program and a pediatrician’s practice. We will focus
on the family as the mother-father-infant triad. At a single home visit, families will complete face-to-face
interviews (mother and father only), be videotaped for a short coparenting interaction (triad) and have a buccal
mucosal sample (for telomere length) and hair (for cortisol) collected (infant only). Family stress, family
resources and infant development will incorporate valid and reliable instruments successfully used in prior
studies with Arab families and are translated into Arabic language. This study will provide preliminary data for a
larger study to examine the associations of family stress and family resources with coparenting and infant
outcomes among immigrant Arab American families. Understanding mechanisms through which family stress
and family resources influence coparenting and ultimately infant outcomes among immigrant families will guide
the development of coparenting interventions to prevent the negative effects of family stress on infant
outcomes and the intergenerational transfer of stress and trauma.

Public health relevance
PROJECT NARRATIVE Immigrant Arab American families experience migration-related stress. Family stress is associated with negative infant outcomes. In contrast, family resources may improve infant outcomes. This study will focus on the association of family stress, family resources, and coparenting with infant outcomes (hair cortisol and salivary telomere length) among immigrant Arab American families.